Investigating the Genetic Landscape of Cerebral Palsy

PROJECT SUMMARY/ABSTRACT
Cerebral palsy (CP) is the most common childhood-onset motor disability, affecting 764,000 individuals
in the United States alone. The lifetime medical costs for a single individual with CP are estimated at $1.4M,
which represents a substantial healthcare and economic impact. A diverse set of risk factors contributes to CP,
including prematurity, intrauterine infection, and hypoxic ischemic encephalopathy. In approximately 20% of
cases, there are no clear perinatal risk factors (“cryptogenic CP”). There is accumulating evidence from rare
familial cases and a growing number of isolated cases suggesting that cryptogenic CP may result in part from
single gene disorders, including over 50 treatable inborn errors of metabolism. However, these studies have
involved small numbers of participants, with patient populations characterized using administrative data with
limited attention to precise clinical characterization. The full breadth of the genetic landscape of CP is
unknown.
We hypothesize that a substantial portion of individuals with cryptogenic CP will have a pathogenic or
likely pathogenic variant in a single gene providing an explanation for their symptoms. We propose rigorously
phenotyping a large prospective cohort of individuals with both cryptogenic and non-cryptogenic CP who have
undergone exome sequencing through an institutional genomics pilot study, and then analyzing exome
sequencing data to determine the presence of single gene disorders in each subgroup.
To accomplish these goals, we will classify patients as cryptogenic CP or non-cryptogenic CP. We will
systematically, rigorously, and longitudinally characterize neurological, motor, communication, and
neuroimaging phenotypes using research measures validated for CP. Next, we will analyze exome data using
an institutional pipeline for variant interpretation. Finally, we will build a statistical model that correlates the
presence of a genetic disorder with phenotypic measures in order to help predict which individuals with CP are
most likely to have a single gene disorder.
If applied to the population at large, the proposed work could lead to identification of single gene
disorders in thousands of individuals with CP, including treatable conditions where a molecular diagnosis may
positively alter a child's developmental trajectory. Determining etiology represents a first step in understanding
the biological substrates of CP needed for developing rational therapeutics for this highly prevalent condition.

Public health relevance
PROJECT NARRATIVE As the most common childhood-onset motor disability, cerebral palsy (CP) affects 764,000 individuals in the United States alone and accounts for lifetime healthcare expenses of $1.4 million per person. In approximately 20% of cases (or 150,000 individuals), the cause is unknown, raising concern for a genetic disorder, including treatable conditions where a molecular diagnosis may positively alter the trajectory of a child's development. This study will determine the genetic landscape of CP, including potentially treatable conditions; develop rules to predict which individuals with CP are likely to have a genetic disorder; and contribute to an emerging scientific understanding of the pathophysiology of CP that will impact a large patient population.